Quantitative Susceptibility Mapping of Brain Iron in People with HIV: Mechanistic Links to Neuropsychiatric Disorders

PROJECT SUMMARY
The public health burden of mood disorders, such as depression, anxiety, and apathy, among people with
HIV (PWH) remains high, despite control of the virus. Neuropsychiatric disorders or symptoms (NPS), afflict 30-
60% of PWH and have risen in prevalence, owing to increased longevity in the combination antiretroviral therapy
era. Furthermore, mood disorders and cognitive impairment frequently co-occur in PWH, are often treatment-
resistant, and present substantial challenges to clinical care overall, due to adverse impacts on adherence to
treatment, quality of life, and functional status. However, the causative mechanisms underlying NPS in virally
suppressed (VS) PWH, and new therapeutic targets, remain elusive.
Mood disorders in people without HIV are known to involve altered iron metabolism, and our preliminary
studies implicate iron imbalances in cognitive impairment and depression in PWH. Iron is essential for
neurotransmitter balance, synthesis and maintenance of myelin by oligodendrocytes, and energy metabolism in
the brain. Iron regulation is disrupted by HIV infection, neuro-inflammation, and a leaky blood-brain barrier (BBB).
It is unknown, however, whether HIV-related changes in iron transport influence brain iron accumulation, which
is linked to many cognitive disorders. Quantitative Susceptibility Mapping magnetic resonance imaging
(QSM/MRI) is a powerful, state-of-the-art neuroimaging technique which can address this research gap by
providing the means to quantify regional brain iron deposition (or load). Specifically, we will 1) Determine
alterations in regional brain iron load in VS-PWH versus HIV-negative individuals, and the contribution of these
alterations to reward and cognitive processes, and 2) Determine the contributions of brain iron, oligodendrocyte
iron-delivery proteins, and altered myelin and dopamine/serotonin homeostasis to disrupted reward and cognitive
processes in VS-PWH versus HIV-negative individuals. The project will employ existing QSM data and
behavioral metrics in RDoC cognitive systems from participants in an ongoing NIH-funded study, to which we
will add behavioral measures in reward processing and biomarkers of iron delivery, myelin maintenance and
mono-amines relevant to frontostriatal function. We will test the central hypotheses that higher brain iron load
in frontostriatal regions will significantly contribute to changes in reward as well as cognitive processes, which
are strongly reliant on prefrontal regions (cognitive control, working memory, attention) in PWH. Findings from
this study will provide the basis for future in-depth mechanistic investigations of mood disorders in VS-PWH and
suggest potential therapeutic targets.

Public health relevance
LAY NARRATIVE Mood disorders, including depression, and loss of motivation are extremely common and debilitating in people with HIV, despite effective antiretroviral therapy. These disorders are likely to be related to changes in systemic and/or brain iron metabolism. This study will use new and state-of-the-art brain imaging techniques to measure brain iron in people with and without HIV infection and determine its contributions to depressive and other mood- related symptoms.